Cancer Training in Disparities and Equity (C-TIDE)

PROJECT SUMMARY
This new application proposes a research training program in cancer disparities and health equity across
the cancer control continuum at the University of Miami (UM) Miller School of Medicine (MSOM) and the
NCI-designated Sylvester Comprehensive Cancer Center (Sylvester). The South Florida Cancer Control
Training in Disparities and Equity (South Florida C-TIDE) is interdisciplinary program that targets training in
multilevel determinants (e.g., biological, medical, social, psychosocial) of cancer etiology, prevention, risk,
progression, adjustment, health-related quality of life (HRQOL), and other health- and patient-reported
outcomes (PROs). The primary goal is to develop the next generation of cancer disparities researchers
by providing exceptional training to support postdoctoral fellows across the cancer control continuum
to develop independent, successful, high-impact research in cancer health disparities and equity. Two
training tracks will be offered: Track A: Multilevel determinants of cancer disparities in etiology, risk, and
outcomes; and Track B: Innovative interventions to reduce disparities and improve outcomes across the
cancer continuum. Trainees will select a primary track of emphasis; although, training will cut across both
domains. The program goals are achieved via mentored, didactic, and experiential exposures within MSOM,
Sylvester and the center’s catchment area. The program will be supported by 24 primary mentors who are
funded PIs with grants totaling $16.4M in annual cancer-relevant funding. Mentors include 15 PhDs, 6
MDs, and 4 MD/PhDs across 8 departments. Additionally, 13 mostly junior faculty with relevant expertise will
serve as associate mentors. Collectively, mentors have outstanding expertise in cancer epigenetics,
tumor biology, and biobehavioral mechanisms; sociocultural, behavioral, and psychosocial
determinants of health; community-based screening, lifestyle modification and symptom management,
and survivorship interventions. Training (e.g., didactics, seminars, online modules) aligns with the
competencies to be gained (e.g., social determinants of cancer disparities, intervention science, grant writing)
and capitalizes on Sylvester and MSOM’s access to specific subgroups (e.g., occupational, sexual/gender
identity, race/ethnicity, elderly) and expertise in applied methods (e.g., community-based participatory
research, social epidemiology, epigenetics, psychosocial oncology, eHealth, sociocultural processes). Training
is complemented by enrollment in the Master of Public Health (MPH) or Master of Science in Clinical and
Translational Investigation (MSCTI). C-TIDE will support 3 fellows per year for a total of 15. Most applicants
are expected to have a PhD in a relevant behavioral or social science; some will be MDs with relevant
expertise and interests. Individual development plans (IDPs) will be created for trainees to facilitate oversight
by mentors. Internal, External and Executive Boards, and Diversity and Inclusion, and Arbitration committees
will provide ongoing evaluation and feedback to ensure that the goals of C-TIDE are effectively met.

Public health relevance
PROJECT NARRATIVE This is a new application for an NCI-supported cancer control training in disparities and equity in South Florida (South Florida C-TIDE). This multidisciplinary program proposes to train postdoctoral fellows in multilevel determinants (e.g., biological, medical, social, psychosocial, health systems) of cancer risk, etiology, progression, cancer prevention and care delivery, health-related quality of life, and other patient-reported outcomes. The primary goal of the program is to train the next generation of researchers with an exceptional training platform that supports postdoctoral fellows across the cancer control continuum as they develop independent, successful, high-impact research targeting cancer disparities and health equity.